DEVELOPMENT OF A SALIVARY ASSAY FOR MEASURING PERIODONTAL DISEASE ACTIVITY

Project Summary / Abstract
Periodontal disease (PD) is globally the most common chronic inflammatory disease in humans, which according
to the Centers for Disease Control and Prevention (CDC) affect 47% of U.S. adults 30 years of age or older and
>60% of those over 65 years.1 Given that the course of PD is marked by a discontinuous pattern of disease
activity and inactivity showing exacerbation and remission of tissue destruction,2-4 a critical challenge for
clinicians is not detection of clinical features of periodontal disease, but rather identification of patients who have
an elevated risk for expressing active/progressing disease. Unfortunately, current guidelines and classifications
rely exclusively on clinical and radiographic measurements to identify existing disease. While these records are
a good reflection of a patient’s past history,5, 6 they fail to provide information on the current status of active
disease or identify individuals and sites at risk for future disease.4, 5 This is because active disease involves
tissue destructive processes (biologic phenotype)6, 8, 9 that precede and subsequently trigger the resulting clinical
signs and symptoms (clinical phenotype). A host of salivary biomarkers for PD have been identified7, 10, 11 and
multiple commercial assays are currently available for use in the clinic, but most lack specificity for tissue
destruction and/or are not amenable to point-of-care (POC) real-time testing. Matrix metalloproteinase-8 is
amongst the most widely documented, abundant biomarkers in saliva, and uniquely suited to quantitatively
assess the extent and degree of tissue destruction.8, 9, 12-14 As an enzyme, it is present in both active and latent
(inactive) forms, the relative expression of which dictate the extent of tissue breakdown during active periods of
disease.8, 9 Hence, we hypothesize that the ratio of active and total MMP-8 (MMP-8Active/MMP-8Total) will constitute
a more meaningful biological measure of disease activity than total MMP-8. However, measures of disease
activity to date have not been possible due to the lack of commercially available antibodies for “active” MMP-8.
Building off our team’s success in development of Disease Activity Specific Monoclonal Antibody (DASMAB)
against MMP-8, we propose here to leverage these unique assets to develop a targeted molecular assay for
quantifying disease activity. In this Phase I proposal, we plan to develop and validate an optimized DASMAB-
based ELISA assay through the following aims: (1) identify and select the best mAb pairs (capture and detection)
for each MMP-8 form to produce ELISA kit prototypes, and (2) analytical and clinical validation of disease activity
of ELISA prototypes. Successful development and validation of the first DASMAB-based disease activity assay
will precede a clinical POC diagnostic product that will offer clinicians with not only the means to quantify the
extent and estimate the rate of disease progression in real-time, but also assess response to therapy and predict
the most likely outcome of future events. These technological innovations will allow clinicians to make more
effective outcome-driven decisions and personalize preventive strategies to improve patient care.

Public health relevance
Project Narrative We propose leveraging the unique capabilities of CellectGen’s Disease Activity Specific Monoclonal Antibody (DASMAB) technology to develop the first antibody-based ELISA assay for measuring periodontal disease activity. Successful development and validation of this assay will precede development of a clinical diagnostic product that could significantly improve our ability to assess periodontal disease progression in real-time, prior to clinical signs of irreversible damage.